Wearable Electrostrictive Row-Column Ultrasound Arrays for Longitudinal Echocardiography

Project Summary / Abstract
In patients admitted to intensive care units (ICUs) with shock (low blood pressure) that results in both clinical
and biochemical evidence of tissue hypoperfusion due to inadequate cardiac output, clinicians commonly seek
to assess and monitor cardiac function, but all available invasive and non-invasive methodologies have
significant limitations and/or risk. The gold standard method to assess cardiac output and shock states is a
pulmonary arterial catheter (PAC) which is inserted through a venous canula and passes through the right side
of the heart into the pulmonary artery. The advantages of this modality are that it provides information on right
and left heart pressures, and allows for the calculation of cardiac output via thermodilution techniques. Its
disadvantages include the invasive nature resulting the potential risk of vascular injury. Moreover, cardiac
outputs are inaccurate in common cardiac arrhythmias (ex atrial fibrillation) and valvular lesions (ex tricuspid
regurgitation), and only provides information on overall cardiac function without direct information on left and
right heart function. Non-invasive cardiac output monitors (NICOMs) use proprietary bio-impedance or arterial
line area under the curve algorithms to estimate cardiac output. While these are minimally invasive, they have
not been well validated in patients in cardiogenic shock and provide no information on left and right heart function.
Finally, point of care ultrasound (POCUS) allows echocardiographic evaluation of left and right heart function,
but it is not well suited for evaluation of continuous or temporal trends in cardiac function given it requires a
clinician to acquire images at the bedside. A wearable ultrasound probe that would enable hands-free
longitudinal imaging of patients would prove to be of considerable value in the ICU environment.
In this proposal we introduce a radically new wearable ultrasound technology, bias-sensitive electrostrictive top-
orthogonal-to-bottom electrode (TOBE) arrays. These TOBE arrays offer readout from every element of a 2D
array through biasing control and transmit-receive control of only rows and columns, rather than require wiring
from every element. With novel readout approaches, these arrays will be demonstrated to achieve image quality
comparable to a linear array, but with full electronic 3D scanning capabilities. Unlike MATRIX probes that rely
on complicated micro-beamformers, our approach is simpler, yet allows for advanced imaging modes such as
ultrafast imaging at thousands of frames per second. We propose the development of such ultrafast imaging
modes with wearable TOBE probes for angle-agnostic flow estimation and longitudinal electronic tracking of right
and left heart function. The angle-agnostic flow estimation avoids errors due to unknown Doppler angles and
mitigates the need for manual probe positioning. In this proposal, we aim to further develop the transducer
technology, interfacing electronics, and imaging methods to enable angle-agnostic flow imaging in phantoms,
then with first-in-human imaging. We aim to establish feasibility data for future research into advanced
longitudinal monitoring of cardiac output, ejection fractions, pulmonary artery pressure, etc.

Public health relevance
Project Narrative: A fundamentally new form of label-free non-contact microscopy, Photoacoustic Remote Sensing, is combined with Ultraviolet-excited Autofluorescence imaging to form histopathological imagery with extremely close correspondence to conventional histopathology, while additionally providing information about tissue metabolism. The technology is proposed to be developed into both a high-resolution scanning microscopy system as well as a widefield camera-based system for rapidly imaging lumpectomy specimens or even resection beds for intra-operative surgical guidance. This technology is expected to reduce the need long-waits of histopathology and mitigate the need for repeated oncologic surgeries.